Immunology Training

The long-standing Immunology Training Program at The Scripps Research Institute currently
provides advanced research training for 5 postdoctoral fellows in diverse areas of immunology.
One additional position is requested to support a total of 6 postdoctoral trainees each year. The
24 designated Mentors, remaining faculty of Scripps and the interactions with the La Jolla
immunology community provide a rich, challenging, multidisciplinary, and highly collaborative
environment for trainees. The goals of this Immunology Training grant remain unchanged: to
recruit and train the best candidates from a diverse applicant pool to become independent
scientists with promising careers in basic and applied immunology. Underrepresented minority
candidates and both Ph.D. and M.D. candidates are encouraged to apply. An individualized
training and mentoring plan is designed for each trainee including training in research ethics,
biostatistics, communication skills, grant preparation, career options, and proper use of human
subjects and animals in research. The 24 designated Mentors have a distinguished record of
training postdoctoral fellows and have research interests that include autoimmunity, innate
immunity and inflammation, lymphocyte biology, signal transduction, structural immunology, and
viral immunology. The Immunology Training Program will continue the tradition of training highly
productive, independent, creative scientists who will make substantial contributions to the field
of immunology and related disciplines.

Public health relevance
The Immunology Training Program at The Scripps Research Institute has provided training to postdoctoral fellows for 34 years and trained creative, independent scientists to make meaningful contributions in diverse areas of immunology. Six postdoctoral training positions are requested for the next five years to continue this long-standing training program.